CLINICAL RESEARCH OPERATIONS AND MANAGEMENT SUPPORT (CROMS)

The objective of this contract renewal is to continue operations and management support services for clinical research studies supported by the National Institute of Dental and Craniofacial Research (NIDCR) within both the extramural and intramural research divisions. The contract provides staff with tools essential for the effective administration and coordination of NIDCR’s clinical studies. It provides technological support for the maintenance and updates to the custom NIDCR-Clinical Research Management System (CRMS). In addition, it provides adjunct expertise and resources to assure sound and efficient clinical study documentation, clinical site monitoring, and data and safety monitoring support. Specific tasks performed varies by clinical study.